Cortico-amydala circuit dysfunction underlying avoidance behaviors and aversive facial expressions to social touch in mouse models of autism

PROJECT ABSTRACT
Autism spectrum disorders (ASD) are neurodevelopmental disorders characterized by deficits in social
interaction, repetitive behaviors and atypical sensory processing. The change in quality of life in ASD individuals
is primarily attributed to social deficits, which can be associated with (or even triggered by) atypical processing
of sensory information. In particular, social touch deficits in ASD may explain this association given the strong
relationship between social interaction deficits and tactile hypersensitivity in ASD. Early tactile hyperresponsivity
predicts future social impairments in ASD children and the absence of touch prevents ASD children from forming
social relationships as adults. ASD individuals also lack representations of affective social touch in
somatosensory brain regions. In mouse models of ASD, tactile sensitivity and social touch interactions also
appear to be linked. Still, several important questions about social touch remain unresolved. First, it is not known
when social touch behavioral deficits first emerge in ASD. These deficits may emerge early on in development
when sensory hypersensitivity first develops or later in adolescence when social experiences become more
frequent. Second, little is known about how social touch and maladaptive behaviors to social touch are
represented in the brain of ASD individuals. Relevant brain areas may include the primary somatosensory cortex
(S1), which encodes social touch and shows impaired adaptation to innocuous tactile stimuli in ASD mouse
models, and the basolateral amygdala (BLA), which is important for encoding aversive stimuli and salient social
information. To investigate social touch deficits in mouse models of autism, I have designed a novel head-fixed
behavioral assay during which behavioral responses to social touch can be measured. This assay allows me to
spatially and temporally control social touch interactions between mice so that I can assess the behavioral
responses to both voluntary (whisker-whisker contact) and forced (snout-snout contact) social touch in a test
mouse as it interacts with a stranger mouse. My preliminary data already shows that both the Fragile X Syndrome
and maternal immune activation mouse models of autism animals display increased avoidance behaviors and
aversive facial expressions (AFEs) to both voluntary and forced social touch compared to their controls in
adulthood. Furthermore, these maladaptive behaviors are more prominent during social touch than object touch.
For this proposal, I will utilize this novel behavioral assay and in vivo silicon probe electrophysiology recordings
(Neuropixels) to 1. investigate when avoidance behaviors and AFEs to social touch emerge during development
(postnatal and juvenile ages) in ASD mice and 2. determine how social touch and the maladaptive behavioral
responses it triggers in ASD are represented as neural dynamics in S1 and BLA. This proposal is significant
because it will provide the first characterization of behavioral manifestations of social touch deficits across
development and investigate the neural circuit disruptions underlying these deficits in mouse models of ASD.

Public health relevance
PROJECT NARRATIVE The change of quality of life in autism spectrum disorders (ASD) individuals is primarily attributed to social deficits, which may be associated, or even triggered by, atypical sensory processing, specifically tactile hypersensitivity. However, this relationship has not been investigated extensively and could be best explained by looking at how mouse models of ASD maladaptively respond to social touch and how social touch is encoded in the brain of these ASD models. This project will utilize a novel head-fixed behavioral assay in mice to investigate when avoidance behaviors and aversive facial expressions to social touch first emerge in development and neural circuit disruptions in the primary somatosensory cortex and basolateral amygdala (S1- BLA) circuit that underly social touch deficits in mouse models of ASD.